Unsupervised image processing methods for cryoEM analysis in real time

Traditionally, imaging experiments involve a linear workflow with sample preparation followed by data acquisition and analysis. In this workflow, data acquisition is often conducted manually-a researcher sits at a microscope and decides which particle, cell or tissue section to image. These procedures not only make imaging experiments incredibly time and labour intensive, they also limit the volume of data that can be acquired and can create biased data sets. With the advent of robotics for sample preparation and completely automated microscopes, it is now time to upscale imaging experiments to generate larger and better data sets through integration of analysis during data acquisition.